Human CDX2 Cells and Cardiac Repair

Project Summary
Fetal-derived placenta cells are known to enter the maternal circulation during pregnancy and may persist in
maternal tissue for decades as microchimeras. We have reported that fetal cells selectively home to injured
maternal myocardium and undergo differentiation into diverse cardiac lineages. Using enhanced green
fluorescent protein (eGFP)-tagged fetuses, we demonstrated engraftment and cardiac differentiation of
mulitpotent fetal cells in injury zones of maternal hearts. In vitro, fetal cells isolated from maternal hearts
recapitulate these differentiation pathways, forming vascular tubes and spontaneously beating
cardiomyocytes in a fusion-independent manner. A significant proportion (~40%) of fetal cells in maternal
hearts express Caudal-related homeobox2 (Cdx2), previously associated with trophoblast stem cells.
Utilizing cre-lox technology for lineage-tracing, we have now shown that Cdx2 cells can be isolated from
end-gestation placenta and can form beating cardiomyocytes and vascular cells in vitro. Furthermore, they
exhibit a transcriptomic signature that suggests an ability to evade host immune surveillance. Proteomic
studies of these cells compared to ES cells reveal distinct growth, survival and homing advantages, but with
retention of the `stemness' properties of ES cells. Thus the transcriptomic and proteomic analysis reveal
desirable qualities that can aid in the development of an allogeneic cell therapy approach. In further support
of this objective, we have demonstrated that Cdx2 cells home robustly and specifically to infarcted hearts
upon injection into the tail vein, with differentiation in vivo to cardiomyocytes and blood vessels. MRI
demonstrates significant and sustained enhancement of contractility (manuscript in revision at PNAS). We
have also shown that CDX2 cells can be isolated from human term placentas. Our final goal is to translate
these studies for clinical use, and we propose three aims utilizing the most cutting-edge technologies in
science in order to achieve this. In aim 1, we will uncover unique cell surface markers of human CDX2 cells
via trancriptome/proteome profiling and explore their homing mechanisms. In aim 2, we seek to understand
immunologic properties of these cells in order to aid in the development of allogeneic human cell therapy.
We will also ascertain their propensity to form teratomas. In aim 3, we will confirm that CDX2 cells also give
rise to functional cardiomyocytes and vascular cells in vitro and in vivo after myocardial infarction (MI) is
induced in wild-type and NOD/SCID mice. We will also test whether these cells enhance myocardial
function after MI, as this will aid us in designing a therapeutic strategy.

Public health relevance
Project Narrative Our laboratory has discovered that stem/progenitor cells of fetal origin found in the placenta appear to repair the diseased heart and can form functioning heart muscle cells and blood vessels. They also repair the heart when injected intravenously into mice with infarcted hearts. We have found these cells in term human placentas as well, and now we propose to develop these findings such that we can isolate these cells from otherwise discarded human placentas for broader use in regenerative medicine.